Project 2 - Toxicant-Stimulated Disruption of Gestational Tissues with Implications for Adverse Pregnancy Outcomes

SUMMARY
Established in 2010, the PROTECT Superfund Research Center integrates research, training and stakeholder
engagement to provide solutions for reducing pollutant risks to pregnancy in Puerto Rico and nationwide. This
project contributes to the mission of PROTECT with toxicological studies of disruption of the placenta and
extraplacental membranes as potential mechanisms of preterm birth. Experiments will use explant cultures of
primary human placental villous and extraplacental membranes (EPM) from healthy term deliveries as highly
relevant human tissue models that allow experimental manipulation for toxicity assessment and avoid
complications of inter-species differences. This proposal continues study of Superfund chemicals relevant to
Puerto Rico – di-(2-ethylhexyl) phthalate (DEHP) and trichloroethylene (TCE) – with addition of di-(2-
ethylhexyl) terephthalate (DEHTP) which is an alternative phthalate of increasing commercial use that is
structurally related to DEHP. Because most adverse health effects of phthalates and TCE are attributed to
metabolites, experiments will be conducted with systemically distributed metabolites of DEHP (mono-[2-
ethylhexyl] phthalate and mono-[2-ethyl-carboxypropyl] phthalate), DEHTP (mono-[2-ethylhexyl] terephthalate
and mono-[2-ethyl-5-carboxypentyl] terephthalate), and TCE (trichloroacetate and S-(1, 2-dichlorovinyl)-L-
cysteine). Furthermore, we will assess the combined exposure of the aforementioned phthalate metabolites in
a reconstituted mixture based on their relative urinary concentrations in Puerto Rican women. Because the
placenta is highly perfused, these blood-borne metabolites are efficiently delivered to the placenta in exposed
women. This proposal builds on current knowledge – and past successes of this project and center – to
propose the overarching hypothesis that phthalate and TCE metabolites activate oxidative stress upstream of
cytokine responses that disrupt the function of the placenta and EPM, thereby contributing to risk for preterm
birth. In Aims 1 and 2, we will use human placental villous explants to establish concentration-dependent and
time-dependent relationships for the phthalate and TCE metabolites (Aim 1), and test whether oxidative stress
initiates tissue function disruption by these toxicants (Aim 2). Because infection of the placenta and EPM is the
leading identifiable cause of preterm birth, in Aim 3 we will probe oxidative stress as a mechanism by which
toxicants modify susceptibility of EPM to Group B Streptococcus (GBS) infection. The proposed studies will
expand knowledge of phthalate and TCE toxicity to placenta and EPM, providing new insights into stimulation
of oxidative stress and inhibition of gestational tissue resistance to bacterial infection as biological mechanisms
by which environmental contaminant exposures increase risk for preterm birth. By working with primary human
tissue culture models relevant to late preterm birth – which accounts for most of the increase in preterm births
in the United States – these findings have the potential for translation to medical and public health
interventions with a significant impact on reducing preterm births.

Public health relevance
PROJECT NARRATIVE Preterm birth and low birth weight are expensive, dangerous and prevalent, with particular concern for high rates of these adverse pregnancy outcomes in Puerto Rico. By delivering insight into underlying mechanisms, findings from this project will contribute to strategies for integrative solutions to reduce preterm birth and low birth weight with interventions at the individual, community, clinical, and state or federal levels.